BLRD Merit Review Research Career Scientist Award

This proposal seeks to renew Research Career Scientist Award held by Dr. Shyam S Mohapatra,
at the James A. Haley VA Hospital in Tampa, Florida since 2007. He is a Distinguished Health
Professor and the Director of the Division of Translational Medicine- Center for Research and
Education in Nanobioengineering at the VA-affiliated academic center- the University of South
Florida. With ~235 publications, 40 patents, an h-index of 53 and an i-index of 161, he is recognized
nationally and internationally for his contributions to the field of nanoscale biomedical diagnostics
and therapeutics in relation to viral infections, traumatic brain injury (TBI) and cancers. He has
received substantial extramural research support including awards from the NIH, DOA, ONR,
Department of Veterans’ Affairs and Florida Department of Health. He is the recipient of several
international/national awards and recognitions. Dr. Mohapatra has been a research investigator at
the VA Hospital (Medicine) since 1996 and has been continuously funded with the Merit Review
Award focused on respiratory syncytial virus (RSV) infection since 1999. Current and ongoing
research activities to be supported by this RCS Award are as follows.
Project #1. a) Develop new prophylactic, or therapeutic approaches involving broad antiviral
and anti-inflammatory compounds formulated using novel nanoscale technologies, which are
effective against COVID-19 and other respiratory viral infections. The currently proposed Merit
Review project aims to develop a simple, smart and translatable nanoscale system that combines
novel targets for antiviral- and replication and inflammation inhibitors. He currently leads two
additional projects, as a multi-PI. This proposal aims to characterize novel virus-neutralizing particles
that may serve as prophylaxis and/or therapy. b) Also, based on his recent experience in artificial
intelligence (AI)-enhanced imaging, and preliminary data with COVID-19, he was funded by CSRD
to examine the potential to clinically diagnose and prognose COVID 19 by AI-aided chest CT.
Project #2. Investigate and test a novel targeted oncolytic viro-cell therapy (OVT) for lung
cancer using the mesenchymal stem cell (MSCs) infected by RSV, which is harmless for
immunocompetent individuals. Thus, it is planned to use a 3D multicell tumoroid and biopsy-derived
cultures in vitro and mouse model of lung cancer in vivo to evaluate the safety and efficacy of OVT.
The project to data has attracted industry collaboration, which might lead to clinical trials.
Project #3. Investigate the potential of a novel combinatorial therapeutic approach in a
mouse CCI model of moderate TBI that includes (i) a treatment to reduce inflammation (local and
systemic) using a nano-formulated siRNA against a recently discovered target, CCL20, and (ii) a
second treatment to promote neuroregeneration by MSC therapy.
VA Impact: These highly innovative applications of nanomedicine approaches taken
together are expected to lead to high-impact clinical diagnostics and therapies for Veterans and
other Americans in need. Veterans have been proportionately affected by the pandemic, and are
increasingly affected by the incidence of lung cancers and TBI compared to the general population.
The development of these effective nanotherapeutics will greatly improve the quality of Veteran’s
healthcare.

Public health relevance
Emerging nanomedicine technologies have the potential to advance both diagnostic and therapeutic goals of diverse human diseases and already led to several products in the marketplace. Thus, nanoformulations developed in James A. Haley VA Hospital, Tampa is expected to advance the delivery of new drugs for respiratory virus infection-induced pneumonia for which elderly Veterans are a major target. Further, it is planned to investigate collaboratively with other VA scientists the potential of a novel combinatorial therapeutic approach involving nanoformulations of short interfering RNA (shRNA) against CCL20 and mesenchymal stem cells for Veterans with mild or moderate traumatic brain injury. Also, a nanofiber-scaffold-based 4D tumoroid assay will be used for clinical drug efficacy testing and personalizing cancer therapy in Veterans.